Temporal Trends in Transfusion –Transmissible Infections Risks and Monitoring of Donor Risk Factors in the US Blood Supply Project (TTIMS)-Non-AIDS

Funding will be used to add controls to Risk Factor Evaluation Assessment of HIV, Hepatitis B and C positive donors within the Temporal Trends in Transfusion-Transmissible Infections Risks and Monitoring of Donor Risk Factors in the US Blood Supply Project (TTIMS).